New CRISPR tools for systematic interrogation of genetic and transcriptional determinants of antibiotic sensitivity in bacteria

Project Summary
Antibiotic resistance is one of the biggest threats to today’s public health. Mechanisms underlying antibiotic
resistance are extremely complex and have both genetic and non-genetic components. For instance, transient
tolerance of antibiotics by transcriptional reprogramming (non-genetic) in subpopulations of bacteria could aid
in the ultimate rise of mutations (genetic) conferring resistance, leading to recurrent treatment failure and the
emergence of multidrug resistance in the clinic. This has been seen in cases of adaptive resistance and
bacterial persistence. A systems-level survey of genetic and transcriptional determinants influencing antibiotic
sensitivity will generate a strong foundation for developing novel antimicrobial strategies. In particular,
identification of factors that sensitize bacteria to specific antibiotics (drug potentiation) is a viable strategy to
confront resistance. Using transposon mutagenesis, previous studies have unbiasedly assessed the
contribution of every non-essential gene to antibiotic sensitivity in many bacterial species. However, due to its
irreversible perturbation and inability to target essential genes, transposon mutagenesis is not ideal for
studying phenotypes that have a transient, non-genetic component such as persistence. In order to address
this challenge, I propose to develop a systematic framework using a novel genome-wide CRISPR-interference
(CRISPRi) screening technology to interrogate the genetic and transcriptional determinants of antibiotic
sensitivity. Compared to conventional design-based, low-diversity guide-RNA (gRNA) libraries generated using
array-based oligonucleotide synthesis, the proposed technology harnesses the natural capacity of the CRISPR
adaptation machinery to convert genomic DNA into comprehensive genome-wide crRNA (analogous to gRNA)
libraries. My preliminary results show that this approach can greatly reduce the expense, labor and time
required for the generation of CRISPR libraries, while substantially increasing their diversity and sensitivity,
thereby revealing novel genetic loci not previously implicated in antibiotic sensitivity. Moreover, compared to
the strong loss-of-function perturbation caused by transposon mutagenesis, the diverse crRNA members of the
library are expected to create a wide range of transcriptional repression. This will allow us to survey a much
broader fitness landscape, crucially including the mild suppression of essential genes. Using this proposed
genome-wide CRISPRi library and an inducible version of it, along with other techniques including ORF
overexpression libraries, bacterial genetics, computational analysis and animal models, I will carry out a
systems-level investigation of the genetic and transcriptional determinants underlying antibiotic sensitivity, and
the under-studied gene-level collateral sensitivity in two evolutionary distinct bacteria of basic and clinical
importance: Escherichia coli and Staphylococcus aureus. I expect results from these proposed experiments to
substantially expand our knowledge on the diverse genetic and non-genetic mechanisms of antibiotic
resistance and yield novel targets for drug development.

Public health relevance
Project Narrative Mechanisms underlying antibiotic resistance are extremely complex and have both genetic and non-genetic components. Here, I propose to develop a systematic framework utilizing a novel comprehensive genome-wide CRISPR-interference (CRISPRi) technology to interrogate the genetic and transcriptional determinants of antibiotic resistance in bacteria (with a focus on Escherichia coli and Staphylococcus aureus). The substantially improved sensitivity and versatility of the technology, along with computational tools and animal models, is expected to reveal rich insights guiding the rational design of new drugs and drug combinations.